Geriatric-Specific Risks and Outcomes in Older Kidney Tranplant Recipients

DESCRIPTION (provided by applicant): In the US there are over 400,000 older adults with end stage renal disease (ESRD), representing the fastest growing age group with this disease. In 2005, 74,864 older adults developed ESRD, while 5,748 underwent kidney transplantation (KT). KT is a relatively new practice in older adults, so little information is available for risk prediction. We recently showed that standard comorbidities captured by kidney and transplant registries are poor predictors in older KT recipients (AUC only 0.66 in a national cohort of 6,988 patients). Our preliminary data supports that factors not captured by registries are needed to improve risk prediction. We hypothesize that a panel of geriatric-specific metrics will improve risk prediction in older KT recipients. Utilizing measures from gerontology literature including frailty, activities of daily living (ADL), instrumental ADL (IADL), and lower extremity disability,is likely to improve outcomes prediction in older KT recipients. Although graft and patient survival are important, older adults strongly value other outcomes, like health-related quality of life (HRQOL). This patient-centered outcome provides a broad summary of how patients perceive their health and has been shown to improve after KT; however in older KT recipients, no studies have documented the natural history of HRQOL or identified risk factors for low HRQOL following KT. Another important KT goal is hospitalization-free survival. Our preliminary data show that while the number of hospitalized days in the first year post-KT was relatively consistent in younger adults, variability was high among older KT recipients. Similar to HRQOL, there are no risk models for hospital-free survival after KT in older adults. To enhance risk prediction in older KT recipients we propose: 1) To quantify the association of geriatric-specific risk metrics and mortality in older KT recipients, 2) To identify predictors of health-related qualty of life in older KT recipients, and 3) To identify predictors of days spent hospitalized in the firt year following KT in older recipients. A better understanding of which older KT recipients will do well after KT, and which will do poorly, is critical for patient selection, counseling, and clinica decision-making.

Public health relevance
PUBLIC HEALTH RELEVANCE: As the number older adults with end stage renal disease, currently over 400,000, continues to grow it is vital that we improve risk prediction for kidney transplantation (KT). Healthcare providers are unable to accurately predict which older adults will benefit from KT and which will be at increased risk for adverse outcomes. The goal of the proposed research project is to quantify the impact of geriatric-specific risk metrics on mortality as well as other adverse outcomes important to older adults like health-related quality of life and hospitalization. Geriatric-specific metrics are important predictors of outcomes in older adults, and we hypothesize that they will also prove critically important in risk prediction for older aduls considering KT. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In the US there are over 400,000 older adults with end stage renal disease (ESRD), representing the fastest growing age group with this disease. In 2005, 74,864 older adults developed ESRD, while 5,748 underwent kidney transplantation (KT). KT is a relatively new practice in older adults, so little information is available for risk prediction. We recently showed that standard comorbidities are poor predictors in older KT recipients (AUC only 0.66 in a national cohort of 6,988 patients). We hypothesize that geriatric-specific risk metrics will improve risk prediction in older KT recipients. A better understanding of which older KT recipients will do well after KT, and which will do poorly, is critical for patient selection, counseling, and clinical decision-making. We hypothesize that a panel of clinical measures not currently captured in national registries, including frailty, activities of daily living (ADL), instrumental ADL (IADL), and lower extremity disability, will improve outcomes prediction in older KT recipients. Our preliminary data support an association between frailty and adverse KT outcomes: frailty was the strongest predictor of early allograft dysfunction and added predictive power to a comorbidity-based model. However, further exploration of the relationship between frailty and longer-term outcomes, the role of geriatric-specific risk metrics, and the ability to improve prediction models is needed. Although graft and patient survival are important, older adults strongly value other outcomes, like health-related quality of life (HRQOL). This patient centered outcome provides a broad summary of how patients perceive their health and has been shown to improve after KT; however, predictors of HRQOL after KT are unknown. Another important KT goal is hospitalization-free survival. Our preliminary data show that while the number of hospitalized days in the first year post-KT was relatively consistent in younger adults, variability was high among older KT recipients: some older adults spent as many as 120 excess days hospitalized in the first year following KT. Similar to HRQOL, there are no risk models for hospital-free survival after KT in older adults. To enhance risk prediction in older KT recipients, we will take advantage of an ongoing, funded, 4-year, prospective study of 900 participants to address the following aims: Aim 1: To quantify the association of geriatric-specific risk metrics and mortality in older KT recipients. Hypothesis: Frailty, ADL/ IADL, and lower extremity function will improve survival prediction. Overview: We will conduct this study in an established cohort which has measured these 4 geriatric- specific risk metrics in older adults just before KT. Participants have been seen at 1, 3, and 6 months post- KT and every 6 months thereafter. We will study the independent association between frailty, ADL/ IADL dependence, lower extremity disability, and death (established through patient interactions and augmented through outside medical records and the Social Security Death Master File) in older KT recipients. We will also determine if adding these variables to already established risk models improves risk prediction. Aim 2: To identify predictors of health-related quality of life in older KT recipients. Hypothesis: Factors associated with post-KT HRQOL in older adults will overlap but not equal those associated with post-KT survival. Overview: In the same cohort as Aim 1, each participant has HRQOL measured (Healthy Days Measure) at baseline and at each follow-up visit through 1 year post-KT. The pattern of HRQOL after KT will be studied using random effects longitudinal models, with death treated analytically as the lowest possible quality of life. Factors associated with different HRQOL trajectories will be studied in the same analytical framework. Finally, factors associated with low HRQOL at 1 year post-KT (including HRQOL at baseline, geriatric- specific risk metrics described in Aim 1, and other comorbidities) will be determined using modified Poison regression. Aim 3: To identify predictors of days spent hospitalized in the first year following KT in older recipients. Hypothesis: Factors associated with days hospitalized post-KT will overlap but not equal those associated with post-KT survival or HRQOL. Overview: Days spent in the hospital following KT (including the KT admission itself) will be benchmarked to a participant's hospitalization pattern in the year prior to KT, as was done in our preliminary studies. Total days spent hospitalized will be determined, and negative binomial regression (to account for overdispersion) will be used to determine factors associated with prolonged hospitalization. The combined effect of a rapidly increasing incidence of ESRD in older adults, and the profound benefits of KT in appropriate older patients, make the study of geriatric-specific risk and outcome metrics vital to advancing the field of KT. Our findings will strengthen clinical decision-making and improve preoperative and postoperative planning by nephrologists, gerontologists, and surgeons caring for this vulnerable patient population.